RESEARCH SUPPORT CORE 2

SUMMARY: The BAC Recombineering and Transgenic Targeting Core (BRTT) will generate, characterize and distribute specialized transgenic lines requested by the NIDA PSO Center for Molecular and Epigenetic Research of Cell Types Mediating Addictive Behaviors. The BRTT core will be in charge of the following subprojects/tasks: 1) BAC modification of Cre-recombinase and TRAP vectors, 2) Generation of BAC transgenic mice, 3) Histological confirmation of accurate transgene expression, and 4) Archive and distribution of BAC transgenic mice

Public health relevance
RELEVANCE There is great need for cell-type specific transgenic mouse lines that genetically label neuronal populations involved in addictive behaviors to be employed for high throughput translational profiling and to foster a better understanding of the molecular processes underlying drug addiction and chronic pain disorders and accelerate drug development.